Imaging Core

Abstract
The Aim of the Imaging Core is to provide enabling technology in histology and microscopy for all five Junior
Investigators and Pilot Project Investigators in this Developmental Biology COBRE.